Sex specific immune response to SARS-CoV-2 leads to chronic neurologic symptoms

PROJECT SUMMARY
To date over 16 million people in the US have been infected with the severe acute respiratory syndrome
coronavirus 2 virus (SARS-CoV-2), which causes coronavirus disease 2019 (COVID-19). While the vast
majority will survive the acute illness, many are at risk for experiencing long-term symptoms after the acute
illness. Acute neurologic symptoms including encephalitis, strokes and seizures have been reported in COVID-
19 patients. Increasingly, even survivors without acute neurologic conditions have reported neuropsychiatric
symptoms (NPS) months after their illness. The incidence and factors that influence the development of long-
term NPS is unknown. SARS-CoV-2 infection triggers a systemic pro-inflammatory response termed `cytokine
storm', characterized by an uncontrolled release of pro-inflammatory molecules. The consequences of
uncontrolled systemic inflammation on the brain and the link to long-term NPS after COVID-19 is unknown.
Sex differences in the outcome from COVID-19 are increasingly evident. Men have worse outcomes with
acute COVID-19 infection, with higher hospitalization rates and mortality, an effect seen globally. Sex
differences in the immune
literature
acute
inflammatory
circulating
immune
responses underlie the differences i n the acute disease course, as seen both in t he
and in our preliminary data. We have found that men have a more robust innate immune response to
COVID-19 infection, with increased circulating neutrophils and monocytes and higher serum levels of
cytokines and markers of brain injury (neuron specific enolase). In contrast, women have more
T and B cells in response to acute infection compared to men, hallmarks of an antigen-specific
response.Interestingly, our preliminary data suggest that women however, may be disproportionally
affected by the chronic effects of infection, including higher rates of NPS. To examine the mechanism of NPS,
we propose a longitudinal, prospective study to assess the impact of acute and chronic inflammation on
markers of brain injury, and long-term NPS for up to 2 years after COVID-19 infection. To accomplish this, we
will leverage our prospective clinical biorepository and long-term COVID-19 follow-up clinic. To date, over 400
hospitalized COVID-19 patients from three different hospitals have been enrolled into a prospective
biorepository and Houston is now at the verge of another surge. Identifying patients at risk for developing
chronic consequences of COVID-19 infection, and discovering potential underlying mechanisms leading to
NPS will be critical to the enhance the health of millions of COVID-19 survivors.

Public health relevance
PROJECT NARRATIVE Of the millions of people who survive COVID-19, many will be affected by long-term neurologic symptoms. This study will evaluate long-term Neuropsychiatric Symptoms (NPS) and identify sex specific inflammatory profiles that contribute to this pathophysiology. Investigation of the chronic consequences of the disease is necessary as this pandemic will have consequences on public health and the economy for years to come.